Myogenic Mechanisms of Craniofacial Skeletal Muscle Regeneration

Abstract
This application is for an administrative supplement to Mentored Clinical Scientist Research Career Development
Award (K08 DE031029) for Dr. Lauren Katz McKay. She is currently conducting research on craniofacial skeletal
muscle and has observed that this muscle type has a unique regenerative program compared to muscles of the
limb and trunk. This K08 will enhance Dr. McKay’s ability to 1) become an expert in craniofacial muscle stem
cells and regeneration, 2) conduct basic science research at the highest level in a tissue rarely studied, 3) acquire
cutting-edge skills in stem cell techniques including single-cell RNA sequencing (scRNA-seq) and ex vivo cell
transplantation, 4) gain skills in proposal development, manuscript preparation, and data presentation, and 5)
develop a high-quality independent research program that will allow for collaborative opportunities with scientists
and clinicians from across disciplines. To achieve these goals, Dr. McKay has devised a clear and focused
training plan and has identified individuals who are experts in the aforementioned disciplines. Her
multidisciplinary mentoring team consists of: Drs. James White (basic scientist, skeletal muscle regeneration
and stem cells), Shannon Wallet (basic scientist, oral and craniofacial research), Elisabeth Barton (basic
scientist, skeletal muscle regeneration), Kevin Byrd (clinician-scientist, oral stem cells), Lyndon Cooper (clinician-
scientist, oral stem cells), Eric Everett (basic scientist, oral biology), Jimena Giudice (basic scientist, skeletal
muscle research), and Simon Gregory (basic scientist, scRNA-seq). There exists a clinical need to rebuild
functional craniofacial muscle in patients suffering from certain diseases (muscular dystrophy, hemifacial
microsomia), facial trauma, and tumor resections. The lack of a comprehensive investigation of the craniofacial
musculature and its stem population has resulted in a poor understanding of the regenerative capacity of this
tissue when faced with disease or trauma. Our current knowledge of skeletal muscles and their stem cell
populations comes from the limb muscles; however, it is known that distinct differences in embryological origin
exist between muscles of the limb and those of the craniofacial region. Therefore, the objectives of this study
are to use injury models to elucidate the in vivo regenerative capacity of craniofacial skeletal muscle and to
perform deep phenotyping on isolated craniofacial satellite cells to identify molecular targets specific to
craniofacial muscle regeneration. Regenerative capacity will be assessed using in vivo models of muscle
regeneration and in vitro cellular function assays (Aim 1). scRNA-seq and ex vivo stem cell transplantation will
be utilized to identify craniofacial muscle-specific regulators of myogenesis (Aim 2) and identified targets will be
investigated using lentiviral vectors and knockout models (Aim 3). Together, the K08 training and mentorship will
enable Dr. McKay to transition into an independent research career and become a leader in the field of
craniofacial muscle regenerative medicine and translational therapeutics.

Public health relevance
PROJECT NARRATIVE Craniofacial skeletal muscle is essential for basic life functions including chewing, swallowing, and speaking; therefore, understanding how this tissue regenerates in response to injury and disease will provide the basis for therapeutic advances in the treatment of craniofacial muscle diseases and disorders. Our group has demonstrated that craniofacial skeletal muscle has the ability to regenerate following damage, but to what extent remains unknown. The goal of this proposal is to comprehensively investigate the regenerative capacity of craniofacial muscle and its stem cell population to inform developments in treatment modalities for individuals suffering from craniofacial muscle injury or disease.